Enrichment Program

PROJECT SUMMARY – ENRICHMENT PROGRAM
The Enrichment Program promotes knowledge, the exchange of ideas, training, and education in a
culture of multidisciplinary interaction, collaboration, and synergy. It serves as a forum to present and
discuss diabetes research across the translational spectrum through the Annual Chicago Diabetes Day
held on the University of Chicago campus in May and Diabetes & Obesity Research Day held on the
University of Illinois at Chicago campus in October. These meetings provides an opportunity for
investigators with Pilot and Feasibility Studies to present their findings, informs its membership of new
trends, discoveries, programs, grant opportunities, and development in diabetes research. The
Enrichment Program also supports the Midwest Islet Club and Diabetes Research Center leadership
organizes the Kroc Lecture, the Lydia J. Roberts Lecture and the Max Miller Lecture in Diabetes
Research. The Enrichment program supports training and educational opportunities for undergraduate
and medical students, house-staff and postdoctoral fellows as well as for patients with diabetes. The
program has been highly successful and we believe is a “crown jewel” of this Diabetes Research
Center. However, we believe there is also room to improve and in the new five years will implement
new initiatives in the area of diabetes and bioengineering as well as provide direct support for a
diabetes seminar program at the Medical College of Wisconsin.